Decoding Force Transduction Mechanisms of Leukocyte Specific Integrin LFA-1 in Immune Responses

PROJECT SUMMARY
The primary goal of this research is to unravel the force transduction mechanisms of CD18 integrins and their
role in immune cell adhesion and signaling. LFA-1 (CD11a/CD18, αLβ2) is essential for immune cell function,
mediating critical processes such as cell migration, cell-cell adhesion, endothelial extravasation and the
formation of immunological synapses. However, despite its importance, the molecular mechanisms by which
LFA-1 transduces mechanical forces into biochemical signals remain poorly understood. This study aims to fill
this knowledge gap by exploring how specific cytoplasmic proteins interact with LFA-1 to regulate its mechanical
properties and signaling capabilities during immune cell adhesion. The long-term objective of this research is to
deepen our understanding of immune cell adhesion and mechanotransduction pathways, which are crucial for
normal immune function and play a key role in the development and progression of cardiovascular and
pulmonary disease. The specific aims of this project are: (1) to elucidate the temporal dynamics of cytoplasmic
protein associations with LFA-1 during adhesion formation and maturation. By focusing on the regulatory role of
cytoplasmic proteins, this research will identify key molecular players that control integrin affinity and mechanical
signaling. (2) to dissect the force transduction mechanisms of LFA-1 integrin by quantifying molecular orientation
and force during immune cell function. To achieve these aims, the research will utilize cutting-edge techniques
in advanced microscopy, including polarization anisotropy microscopy to measure LFA-1's molecular orientation
and force. Additionally, the project will employ APEX2 proximity labeling coupled with mass spectrometry to
uncover the temporal sequence of cytoplasmic protein interactions with LFA-1 during adhesion. CRISPR-based
knockout strategies will then be used to test the functional significance of these proteins in regulating integrin
activity and immune cell adhesion. The combination of these approaches will provide a comprehensive map of
the mechanotransduction pathways and protein dynamics that govern LFA-1 integrin function. The expected
outcomes of this research will enhance our fundamental understanding of how immune cells use mechanical
information to control adhesion and immune function. By identifying new regulatory proteins involved in LFA-1-
mediated force transduction, this work may also uncover novel therapeutic targets for treating immune-related
cardiovascular and pulmonary diseases. In the long term, these findings have the potential to lead to new
strategies for controlling immune cell behavior, improving treatments for a variety of conditions where immune
dysfunction contributes to disease progression.

Public health relevance
PROJECT NARRATIVE This research seeks to understand how immune cells adhere to other cells and tissues by studying a protein called LFA-1, which helps transmit mechanical signals to inside the cells. By uncovering how LFA-1 turns mechanical signals into chemical signals, we aim to learn how immune cell behavior can be controlled. This knowledge could lead to new treatments for heart, lung and other inflammatory diseases caused or exacerbated by the immune system, improving health outcomes and quality of life.